2021 Mitochondria in Health and Disease Gordon Research Conference

PROJECT SUMMARY
This application seeks partial funds to support the Gordon Research Conference (GRC) on Mitochondria in
Health and Disease to be held August 8-13, 2021. This is the second in a new series of GRCs, which emerged
from the growing awareness within the mitochondrial community of the need for a forum to capture and integrate
a wide range of rapidly evolving areas of mitochondrial biology from the perspective of both basic and
translational science. The GRC format is particularly suited for this forum because it provides a setting where
cutting edge unpublished findings are presented in an inclusive environment that attracts experts across labs
worldwide for a five-day conference. Time for discussions and networking are rigorously protected and
encouraged in every scientific session and through free times in the afternoons. A setting where open discussion
takes place encourages collaboration and is crucial to advancing the frontiers of mitochondrial science. In
addition to accelerating mitochondrial research and promoting cross-disciplinary collaborations, the conference
is committed to enhance visibility and participation of women scientists and minorities. As such, 44% of confirmed
speakers and 44% of discussion leaders in the conference program are women. In addition, short talks from
abstracts will be prioritized to feature research by early career scientists, trainees, women and minorities.
Moreover, a GRC-sponsored Power Hour, which is an open communication forum, is scheduled early during the
conference to discuss challenges surrounding diversity in science. Another conference objective is to train
graduate students and postdocs in mitochondrial science and provide networking and informal mentoring
opportunities to enrich their career development.
The format of the 2021 conference consists of 9 scientific sessions each composed of 3 full talks and one
short talk selected from abstracts, as well as 4 two-hour poster sessions. The scientific sessions will have an
integrative focus on novel molecular, cellular and organismal aspects of mitochondrial bioenergetics and
metabolism, redox regulation, genome integrity, protein biogenesis, and proteostasis, and mitochondria-based
crosstalk mechanisms via carrier systems as well as interorganellar communications. Each session has a
mixture of talks ranging from fundamental biologic mechanisms to physiology/pathophysiology. As such, the
program includes highly diverse topics while featuring frontiers of knowledge gained from a broad range of
approaches, experimental systems and tissue types, as well as investigation of multiple diseases involving
alterations in mitochondrial function. The scientific sessions feature outstanding mitochondrial biologists ranging
from established investigators to early career scientists whose cutting-edge research has had high impact in the
fields of aging, cancer, diabetes and obesity, cardiovascular disease, neurodegeneration, and inborn errors of
metabolism. Given the collective breadth of expertise and research interests within the mitochondrial community,
we believe our program will catalyze productive cross-disciplinary interactions to propel the field forward.

Public health relevance
Project Narrative The mitochondrial biology and medicine field is in continuous and rapid growth, the conference program will feature a wide range of topics related to rapidly emerging areas of mitochondrial biology. It has a dual focus on both basic biologic mechanisms regulating these multifaceted organelles, as well as their relevance in aging- associated pathologies such as diabetes, obesity, cardiovascular disease, neurodegeneration and cancer. In addition, the conference is committed to create unique opportunities for networking and career development for women and underrepresented minorities in science, as well as trainees in the field.